Developing a communication support intervention for cancer caregivers in emerging and young adulthood

Project Summary
Caregivers in emerging and young adulthood account for nearly half of all caregivers in the United States;
however, they are significantly underrepresented in cancer caregiving scholarship. Little is known about their
unique psychosocial needs, and there is a dearth of cancer caregiving resources to support them. Emerging
and young adult caregivers (EYACs, ages 18-35) are a particularly vulnerable caregiving population. They
experience higher rates of psychological distress than their older counterparts, as well as lasting impacts to
their developmental trajectory as a result of their caregiving experience. Caregiving at this age is particularly
challenging when an EYAC must provide care to a parent with cancer, as they must undergo a distressing
relational shift = that creates psychological and communication challenges unique to this patient-caregiver
dyad. Diagnosed parents are known to withhold information about their cancer from their adult children, which
creates further difficulties for EYACs in communicating and coping with their parents. Open family
communication during cancer has been linked to better social, psychological, and physical health outcomes for
both caregivers and patients. Thus, there is a significant need for a communication skills intervention directed
at EYACs of their parents with cancer to help them navigate the interpersonal challenges associated with their
caregiving role that can lead to distress. The goal of this project is to identify the complex communication
needs unique to this age group and adapt an existing caregiver communication skills training intervention
(Healthy Communication Practice, HCP) to meet their age-specific communication needs. The K99 phase of
this project will include two aims: 1) identify EYACs’ unmet communication skill needs via online survey, and 2)
use the survey findings to adapt the intervention materials and pre-test them in EYAC focus groups. The R00
phase of the project will pilot test the new EYAC-tailored intervention for feasibility and acceptability. The
objective of this application will not only create the first communication support intervention specifically
designed for EYACs, but it will also equip Dr. Kastrinos with the necessary skills and training to complete the
proposed research and transition to research independence. She will advance her training in four key areas: 1)
psychosocial intervention development and adaption in cancer caregiving, 2) advanced mixed-method and
quantitative design and analysis, 3) designing and conducting RCTs, and 4) professional skills development.
She will complete both her training and the proposed research with the full support of her mentors (Drs. Allison
Applebaum, Smita Banerjee, Yuelin Li), her collaborators (Drs. Carma L. Bylund and Carla L. Fishers) who are
the creators of HCP, and her advisory board (Drs. Kathryn Greene and Youngmee Kim). At the end of her R00
phase, Dr. Kastrinos will submit an R01 application to test the efficacy of the new intervention in a fully
powered randomized controlled trial. This K99/R00 plan will enable Dr. Kastrinos to achieve her goal of filling a
critical research and resource gap for EYACs and launch a research program addressing their needs.

Public health relevance
Project Narrative Caregivers between the ages of 18 and 30 are known as the “hidden” generation of caregivers – they makeup 43% of all U.S. caregivers and yet are largely absent from caregiving scholarship and supports. Due to their age and developmental stage, emerging and young adults who provide care to a parent with cancer are particularly vulnerable to developing psychological and behavioral problems as a result of their caregiving experience, and previous studies show they want guidance in navigating the interpersonal challenges that arise with their diagnosed parent and within their family during their parent’s cancer. Thus, the aim of this project is to fill this critical resource gap for emerging and young adult caregivers (EYACs) and adapt an existing caregiver communication support intervention to meet the age-specific needs of EYACs who care for a parent with cancer, improving their communication skills and reducing their risks of psychological distress.